Alphavirus determinants of microvascular endothelial cell infection

Project Summary
Alphaviruses are mosquito-transmitted human pathogens capable of explosive outbreaks and devastating
disease. Alphaviruses cause a viremic infection where virus can be disseminated throughout the organism.
Microvascular endothelial cells play critical roles in vascular homeostasis and protecting the vasculature from
invading pathogens. How alphaviruses infect microvascular endothelial cells and how these cells respond to
infection is a major knowledge gap. Filing the gap of viral and cellular determinants of endothelial cell infection
would provide novel targets to block disseminated infection. In preliminary studies to understand chikungunya
virus (CHIKV) infection in primary human cardiac microvascular endothelial cells (hCMECs), we found that the
Indian Ocean Lineage of CHIKV (CHIKV-IOL) was completely restricted in hCMECs, while Asian lineages of
CHIKV and other alphaviruses were not. When we addressed where in the viral life cycle CHIKV was
restriction, we found CHIKV-IOL to be blocked at viral entry and egress, and not genome replication. These
exciting preliminary data allow us to hypothesize that there are both viral and host determinants that restrict
CHIKV-IOL in microvascular endothelial cells at multiple steps in the life cycle. We will test this hypothesis
using primary human microvascular endothelial cells and identifying the CHIKV-specific viral factors that
contribute to hCMEC infection (Aim 1) and investigating hCMEC cellular factors and pathways that restrict
CHIKV-IOL (Aim 2). Understanding how pathogenic alphaviruses are restricted in primary human cells will
identify viral and host pathways we can target to block virus infection, spread, and disease.

Public health relevance
Project Narrative Alphaviruses are significant global public health threats. However, how alphaviruses establish in specific cells is not completely understood. Here, we focus on understanding how alphaviruses infect microvascular endothelial cells in the hopes to identify new avenues to block alphavirus dissemination and disease.